TISSUE CROSS-REACTIVITY STUDY OF A HUMAN ANTIBODY

The test agent is being considered for development as an anticancer therapeutic. The objective of this task was to obtain a source of tissue or cells for in vitro evaluations of toxicity. The information obtained from this investigation was used to identify drugs with the potential to treat cancer.